MAPPING THE INTERACTIONS OF RECA WITH DNA

The Adzuma Laboratory is making an effort to understand the mechanisms of DNA recombination reactions. Their efforts are focused on the homologous recombination reaction catalyzed by RecA. MALDI-ion trap mass spectrometry was used to confirm a binding site of single stranded DNA on E. Coli RecA using photo-crosslinking. A paper describing analytical aspects of the determination of the site of crosslinking (Qin and Chait, Anal. Chem. 69,4002-4009, 1997).